FACS Core

The flow cytometry core will perform flow cytometry based cell sorting experiments for the Projects and assist the project leaders in the design and interpretation of experiments. The core will train students, postdoctoral fellows, research assistants, and clinical invesfigators in the use of analytical instruments and data analysis. In addition, the core will maintain 2 FACSCaliburs and 1 FACSVantage, including daily calibrafion and care, and twice a year preventative maintenance